Investigation of Embodiment for Upper Limb Amputees

Project Summary
Today, prosthetic hands are numb. They provide no tactile or proprioceptive sensory
information back to the user. The lack of sensory feedback has been shown to reduce the utility
of a prosthesis by half. The prosthesis is seen as a tool, not as an incorporated part of the body
schema. Only now are there chronically-implantable technologies which can provide
physiologically appropriate sensory feedback to upper limb amputees to recreate tactile and
proprioceptive percepts. These sensations are the building blocks to enable the embodiment of
the device. Furthermore, newly developed outcome measures are now available which can
detail the improved embodiment such neural interfaces can create. My mission is to enable the
embodiment of artificial devices using peripheral nerve stimulation and thereby close the gap
between the experience of our intact physiological systems and those using prosthetic remedies.
This investigation of embodiment for upper limb amputees is organized into three main areas of
work including 1) normative data collection, 2) device development, and 3) characterization of
embodiment using peripheral nerve stimulation. The normative data collection will quantify
the embodiment of conventional cosmetic, body-powered, and myoelectric prosthetic hand
options using a modified Rubber Hand Illusion protocol (Specific Aim 1). This thrust will ask
how does the amount of embodiment vary among conventional prosthetic hands as well as
probe the relationship between agency and embodiment. The device development project
entails the design of multi-modal sensors in order to study full-hand embodiment (Specific Aim
2). The ability to measure and then elicit sensation on the passive surfaces of the hand (palm,
ulnar border, and dorsal surface) has never been explored. Here, a multi-modal sensor which
can detect proximity, contact, and force will be integrated into a commercially available
prosthetic hand in order to provide detailed measurements across the palm, ulnar border, and
dorsal surfaces in order to study embodiment in more depth. Finally, the characterization of
embodiment using peripheral nerve stimulation will take place over a multiple subject factorial
experiment which quantifies the effects of quantity and spatial parameters of the peripheral
nerve stimulation on the embodiment of prosthetic hands (Specific Aim 3). This study asks
what somatosensory percepts from the hand are most critical for embodiment by varying the
parameters of the peripheral nerve stimulation (quantity and spatiality) and measuring the
level of embodiment in each case. This investigation will be the first thorough (multiple subjects
with peripheral nerve interfaces), systematic (paired factorial design), and exhaustive (using all
electrodes in the neural interface) study to be performed.
Finally, an additional goal to the scientific mission of this proposal is the creation of the Neural
Interface and Sensory Restoration Laboratory in the Rocky Mountain Regional VA Medical
Center. I will direct this laboratory to be a complementary entity to Dr. Tyler’s Functional
Neural Interface Laboratory to study peripheral nerve interfaces with upper limb amputees in
the VA RR&D division. Now, more advanced methodologies can be explored and more
scientific breakthroughs can be initiated with the goal of providing Veterans with amputation an
artificial limb, as opposed to just a prosthetic tool.

Public health relevance
Project Narrative The aim of the Department of Veterans Affairs Rehabilitation Research and Development service is to dramatically improve function of impaired and disabled Veterans. This proposed work will address this aim by studying the embodiment of prosthetic hands for Veterans with upper limb amputation. The loss of a limb can cause physical, psychosocial, and economic damage to an individual and can lead to depression, anxiety, loss of self-esteem, and social isolation. Currently, prosthetic limbs do not provide sensory feedback; they are numb. This causes the device to be seen as a tool, not an incorporated part of the Veteran’s body. Now, neural interfaces can elicit sensory percepts to create embodiment and advanced outcome measures can quantify the psychophysical levels of embodiment. This work will combine state of the art technologies within the VA and strive to recreate what was lost for Veterans with upper limb amputation.